COORDINATION, MONITORING, FOLLOW-UP, AND EVALUATION OF A CLINICAL TRIAL OF NESTORONE TESTOSTERONE GEL FOR MALE CONTRACEPTION

The Eunice Kennedy Shriver National Institute of Child Health and Human Development (NICHD) has a mission to develop safe and effective contraceptives for women and for men. The Contraceptive Clinical Trials Network (CCTN) was established to provide qualified sites the ability to perform clinical trials of new products, including a Statistical and Clinical Coordinating Center (SCCC). The purpose of this Task Order is to conduct work required and to provide the appropriate support services associated with a clinical trial designed to evaluate the daily application of a Nestorone and Testosterone combination gel for male contraception. The current options for men are limited to condoms for reversible contraception or vasectomy for contraception that has very limited reversibility. There is a growing need for new options for male contraception. Consequently, the NICHD has a program to develop novel hormonal drugs for male contraception. Preliminary studies have been completed to demonstrate first-in-man safety, repeat dose gonadotropin suppressive activity, and longer-term dosing that prove that the drugs suppress sperm production. At the conclusion of that evaluation process, a decision was made to pursue drug development to demonstrate contraceptive efficacy in couples. The goal of the current Phase 11B study, CCN0l 7, is to demonstrate safety, sperm suppression and contraceptive efficacy when the product is used by the male partner. It has required large numbers of couples to be recruited to the two main male sites, and with approval from NICHD and Fogarty International as well as State Department clearance, awarded subcontracts to the international sites that had pre-qualified at the time of initial review for selection of CCTN sites for male contraceptive evaluation. The SCCC recruited subcontract partners to provide regulatory assistance with the appropriate regulatory agencies and to monitor clinical trial activity at the international sites. Target enrollment has been achieved such that recruitment has ceased; all remaining couples are expected to complete all activities and phases of the study as outlined in the current protocol. This task order will support the coordination of the clinical trial and all of activities associated with the study. The SCCC will continue to coordinate and monitor the multi-site clinical trial of the combination Nestorone Testosterone Gel for use as a novel male contraceptive product. All sites will continue to transfer data to the SCCC. Upon study completion, the SCCC will collect the data and perform data analysis as well as prepare a clinical study report suitable to support regulatory guidelines to pursue eventual FDA approval of the new drug. The proposed task order will provide continued clinical trial conduct, oversight and monitoring, data analysis and a final clinical study report for the supporting regulatory approval of the novel product for male contraception.

SCOPE
To provide statistical and clinical coordination as well as monitoring of a multi-site clinical trial, including services and support related to protocol changes, logistical support, data collection, database preparation, data analysis and eventual preparation of clinical study report of the clinical trial of a new product for contraception in men.